Mobile Measures of Threat Sensitivity for Cross-sectional and Longitudinal Assessment

Project Summary
Differences in cognitive information processing of threat information have been linked with almost every
major psychiatric illness, from anxiety to psychosis to PTSD. And yet, objective, performance-based
measures of such threat sensitivity tend to be (1) unreliable, (2) difficult to scale, and (3) designed for
assessing differences in phenotypic traits rather than characteristics that vary over time. Self-reported
experiences linked with threat processing (e.g. anxiety, hypervigilance, fear), on the other hand, tend to
fluctuate over minutes, hours, and days within individuals. The lack of brief, sensitive, reliable, and
repeatable measures of threat sensitivity thus represents a major gap in our ability to understand how
threat sensitivity is related to mental health, between individuals and over time. The overall goal of the
proposed project is to develop and validate a battery of optimized and generalizable measures for
assessing between and within-person differences in threat sensitivity, for use in high throughput or high
frequency assessment designs. The proposed work is organized around three specific aims. Aim 1 is to
identify and optimize a set of 5 reliable candidate measures, based on an initial set of 25. We will select
and develop measures based on an iterative test development approach, using high-throughput
assessment in N = 75,000 participants to identify parameters, stimuli, and administration characteristics
that allow us to meet pre-specified psychometric and validation benchmarks across device types (see
Research Strategy). Measures that achieve these benchmarks will then be carried over to two large-scale
EMA validation studies: (1) a sample recruited from an acute psychiatric care setting at McLean Hospital
(Aim 2, N = 200) and (2) a diverse Bronx-biased community sample (Aim 3, N = 400). Successful
completion of this project will yield a set of high-quality measures that are validated for research using
both high throughput and high frequency assessment study designs (e.g. EMA), particularly research that
seeks to characterize the temporal dynamics of threat processing or state-related differences in cognition
and symptoms. The proposed research is significant because it will (1) address a critical gap in our ability
to objectively measure cognitive information processing of threat in field test settings, and (2) provide
robust tools for tracking changes in threat sensitivity over time. The proposed research is innovative in
that it (a) employs an iterative test development approach that will allow us to rapidly select and optimize
potential test candidates, administered in naturalistic environments, and (b) allows us to capture both
between and within-subject variability as potential avenues for identifying mechanisms that contribute to
mental disorders Our team is uniquely positioned to accomplish these aims, given our expertise in
developing and evaluating mobile cognitive assessments, psychometrics, fear and threat information
processing, and infrastructure for disseminating cognitive measures in large cohorts and nationally.

Public health relevance
Project Narrative The proposed research is relevant to public health as it will provide optimized tools for mobile assessment of cognitive information processing in clinical and nonclinical populations, over time, and with greater ecological validity. The project is relevant to NIMH's mission to understand the mechanisms of complex brain disorders as it will provide tools for understanding dynamic variations in cognitive information processing of threat and how these are related to psychiatric symptoms.